The Relationship Between HIV and Fertility in a Context of Expanding ART Access

DESCRIPTION (provided by applicant): Access to antiretroviral therapy (ART) and policies around HIV treatment are expanding throughout sub- Saharan Africa (SSA). Recent improvements in the treatment context in Malawi stand to alter the bi-directional relationship between HIV and fertility in Africa. Of particular relevance is Option B+, a new program designed to provide universal and lifelong access to ART to pregnant, HIV+ women. Because such a policy has never been implemented before, Option B+ offers an important and immediate opportunity to learn about the implications of widespread ART access for reproductive goals and behaviors and the knock-on effects for HIV transmission. The proposed work builds upon longitudinal data collected by Tsogolo la Thanzi (TLT-1) between 2009-11from approximately 3000 young adults living in Balaka, Malawi. Specifically, we seek to field TLT-2: a follow up survey of the TLT-1. TLT-2 will focus on respondents' reproductive, relationship, sexual, contraceptive, and biomedical service use histories. The original cohort will have aged to 21-31-years of peak childbearing and acute risk for HIV infection. We will leverage TLT-2 and the combined TLT-1/TLT-2 dataset to answer questions about women, men, and couples in an environment of widespread and expanding access to ART. In particular, we will measure the expected and possible unanticipated consequences of this new policy on both vertical (i.e., mother-to-child) and horizontal (i.e., between partners) HIV transmission and on patterns of fertility for this cohort. These individual- and couple-level data will be combined with new detailed data collected from clinics and policymakers examining the realities of new policy implementation at the local level. This combined couple-based and institutionally informed approach to understanding the changing relationship between HIV and fertility-a crucial dimension of reproductive health in SSA-stands to inform both research and policy by providing a preliminary evidentiary basis for how other test and treat policies in high-prevalence setting might influence fertility behavior and HIV transmission.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tsogolo la Thanzi-2 will expand an existing data collection project to examine the bidirectional relationship between HIV and fertility in Malawi, where the treatment context is changing rapidly through a new program called Option B+ which initiates HIV+ pregnant women on lifelong anti-retroviral therapy. By assessing how the relationship between AIDS-related phenomena (HIV status, perceptions of risk, etc.) influence fertility preferences and decisions-and vice-versa-over a 6-year observation period, TLT-2 will provide a robust evidentiary basis for informing policy and practice with regard to the integration of HIV and family planning services in SSA.